Defining the impact of mutational drivers on the immune microenvironment of CLL

Project Summary
The dynamic interactions of tumor cells with their microenvironment play an essential role in stimulating cancer
progression, and likely contribute to the pace of clonal evolution and therapeutic resistance. Emerging evidence
suggests that genetic features of cancer cells may impact composition and function of immune cells within the
tumor microenvironment (TME), yet evidence for this remains scant. Recently, we have generated several novel
conditional knock-in/out mouse models of chronic lymphocytic leukemia (CLL) driven by B-cell restricted
expression of human CLL lesions, providing opportunities to model the vast genetic heterogeneity of human
cancers within an immune-competent microenvironment. This current projects seeks to use single cell RNA
sequencing (scRNA-seq) and functional assays to determine the CLL-microenvironment interactions in these
CLL mouse models, and validate the findings in human CLLs. In particular, we will: (Aim 1) Discover the impact
of CLL driver events on the CLL immune landscape. Through scRNA-seq analyses, we will characterize the
immune landscape within the CLL microenvironment, examining both the spleen and bone marrow (BM)
compartments in age-matched controls (Cd-19 Cre transgenic mice) and 4 different genetically-defined CLL
mouse models (Cd19-Cre × MDR, mut-Sf3b&Atm, mut-Ikzf3 and Dnmt3a-deleted). Building on our intriguing
pilot scRNA-seq study conducted in the Dnmt3a-deleted model, we now propose to cross compare the
composition and transcriptional states of immune cells in each model, and to determine whether there are
consistent or unique model-dependent interactions between CLL and immune populations. (Aim 2) Validate
candidate mediators of CLL-TME interactions. We anticipate that we will identify microenvironment changes of
interest either found in common or unique amongst the models, and we will perform flow cytometry and
immunofluorescence (IF)/immunohistochemical (IHC) staining on independent mouse specimens for validation.
We will also perform in vitro co-culture experiments and in vivo transplantation to study the functional interaction
between CLL cells and particular immune cell populations of interest. Indeed, our pilot data from the Dnmt3a-
deleted CLL mouse spleen has already identified an expanded subpopulation of dysregulated dendritic cells, and
we will evaluate if this change is also observed across the other models and the extent to which this change
regulates CLL development. (Aim 3) Confirm the effects of CLL driver events in the TMEs of human CLL. We
will cross compare the mouse scRNA-seq data with that of an existing human CLL scRNA-seq data generated
in the Wu lab. We will perform IF/IHC staining of LN and BM samples from CLL patients to further validate
promising signatures. Altogether, the proposed analyses will expand our knowledge on how cancer cell-intrinsic
features can remodel the tumor immune microenvironment, and has the potential to contribute to the rational
design of personalized cancer immunotherapy.

Public health relevance
Project Narrative Tumor immune landscapes differ greatly amongst individual patients and affect immunotherapy response. However, the impact of cancer genetics on the heterogeneity in immune landscapes has not been systematically explored, and we are still lack clear understanding of these microenvironmental changes. Our mechanistic studies in novel mouse models that can mimic the vast genetic heterogeneity of human chronic lymphocytic leukemia (CLL) will expand our knowledge on how cancer cell-intrinsic features can remodel the tumor immune microenvironment, and are anticipated to contribute to the rational design of personalized cancer immunotherapy.